Homeostatic Mechanisms Regulating Mitochondrial Health

Project Summary/Abstract
Mitochondria are best known as the “powerhouses” of the cell, due to their predominant role in generating
cellular energy through the tricarboxylic acid cycle, fatty acid metabolism, and oxidative phosphorylation
(OXPHOS). Beyond energy generation, these essential organelles also play central roles in apoptosis,
calcium handing, innate immunity, cell signaling, and iron-sulfur cluster assembly. Human health therefore
depends critically on mitochondrial function. The research program proposed here seeks to understand
three homeostatic mechanisms that regulate mitochondrial health. The first mechanism is mitochondrial
fusion and fission dynamics. Mitochondria are dynamic organelles whose physiology is regulated by the
balance between the opposing processes of membrane fusion and fission. Second, the quality of the
mitochondrial population is maintained by selective degradation of excessive or defective mitochondria
through mitophagy, the autophagic pathway that shuttles mitochondria to the lysosome for destruction.
Finally, mitochondrial quantity and function are regulated by biogenesis programs that control expression of
mitochondrial genes, ensuring that appropriate levels of mitochondria are maintained in response to a
specific cellular state. This research project targets key gaps in knowledge in each of these fundamental
homeostatic mechanisms. For mitochondrial fusion and fission, we are using mouse genetics and cell
biology to understand how mitochondrial dynamics regulates mitochondrial function. The least understood
of the core mitochondrial dynamics genes is Fis1. We have found that Fis1 plays essential functions in
neurons, astrocytes, and oligodendrocytes in the central nervous system. We are pinpointing the cellular
functions of Fis1 and determining which function is responsible for the in vivo phenotypes. Our preliminary
data suggest that Fis1 serves as a link between mitochondria and the actin cytoskeleton. Moreover, we are
determining the elusive mechanism through which the balance between fusion and fission is regulated.
There is evidence that each fusion event is coupled to a future fission event, and we will determine the
molecular mechanism of this coupling. To study mitochondrial degradation, we are performing whole-
genome CRISPR interference screens and have discovered the integrated stress response as a key
regulator of mitophagy. We will elucidate the molecular mechanism through which this cell stress pathway
tunes the level of mitophagy. Finally, we are using CRISPR interference screens to identify how
mitochondrial density and function are regulated. These studies have identified two chromatin remodeling
complexes as critical for mitochondrial function. By determining how these chromatin remodeling complexes
regulate mitochondrial biogenesis through control of gene expression, we will gain insight into how cells
dynamically adjust mitochondrial density to fit cellular demands. All together, these studies will provide a
comprehensive understanding of how mitochondrial health in cells is maintained.

Public health relevance
Project narrative (Public health relevance statement) Mitochondria are indispensable organelles that generate energy and perform other vital functions for eukaryotic cells. Human health therefore depends on the proper function of mitochondria, and we are studying the processes that maintain mitochondrial function in cells. In the long-term, advances from these studies can be used to improve mitochondrial function and mitigate disease.